African-ancestry Breast Cancer Genetic Consortium

PROJECT SUMMARY
Breast cancer is the most diagnosed malignancy in the United States. Genetic factors play an important
role in breast cancer etiology, but known genetic factors explain only a small fraction of breast cancer
heritability, particularly in women of African ancestry (AA). In collaboration with investigators from >25 studies
we established the African-ancestry Breast Cancer Genetic Consortium (AABCG) in 2016 to address a
significant racial disparity in breast cancer genetic research that includes primarily women of European
ancestry (EUR). In AABCG, we conducted genome-wide association studies (GWAS) and related analyses
using data from ~18,000 breast cancer cases and ~22,000 controls and reported significant novel findings to
begin filling knowledge gaps. By analyzing whole genome sequencing (WGS) data from a smaller number of AA
women (~1,340 cases and ~670 controls), we provided promising preliminary data in strong support of the important
role of structural variants (SV) and low-frequency and rare single nucleotide variants (SNV) in the etiology of
breast cancer. In this competitive renewal application, we propose a large study including both AA and EUR
women with a major focus on investigating SVs and low-frequency/rare SNV that carry larger effects than
common variants but cannot be adequately studied in GWAS. We plan to expand the AABCG by conducting
deep whole genome sequencing (WGS) in 8,000 AA breast cancer cases and harmonize existing WGS data
from other studies, which will allow us to expand the AABCG’s sample size to approximately 13,800 AA breast
cancer cases and ~80,400 AA controls with deep WGS data. We also will harmonize existing WGS data from
several studies to build a resource containing WGS data from ~27,400 EUR cases and ~534,200 EUR controls.
Using these data, we propose to 1) systematically evaluate low frequency and rare variants, including both coding
and non-coding variants, across the genome to identify novel breast cancer susceptibility variants and genes, and 2)
search the whole genome to identify SVs (both common and rare) associated with breast cancer risk. We will also
evaluate racial differences in the frequency and type of breast cancer associated SNVs and SVs and the strength of
their associations with breast cancer risk. This study will be built upon the success of the AABCG and leverage large
amounts of existing data to substantially enhance the national resources for genetic research of breast cancer in an
extremely cost-efficient manner. With strong methodology and unique data sources, this study will generate critically
needed data that will improve the understanding of breast cancer genetics, biology, and etiology. This will, in turn,
facilitate the translation of genetic findings to cancer prevention and treatment.

Public health relevance
NARRATIVE Breast cancer is the most diagnosed malignancy in the United States. Genetic factors play an important role in breast cancer etiology, but known genetic factors explain only a small fraction of breast cancer heritability, particularly in women of African ancestry. In this application, we propose a large multi-ancestry study to search the whole genome to identify genetic risk factors for breast cancer and evaluate how genetic factors influence racial disparities in breast cancer risk.